Investigating the impact of sickness on the maternal brain and behavior

Project Summary / Abstract
Maternal illness during the postpartum period introduces significant challenges to caregiving, with implications
for both maternal and offspring survival. Postpartum sickness is linked to an increased risk of maternal anxiety,
depression, impaired bonding, and breastfeeding deficits. However, the mechanisms by which sickness alters
maternal neurobiology remain poorly understood. The paraventricular nucleus (PVN) of the hypothalamus is a
critical regulator of maternal caregiving behaviors, housing neurons that synthesize and respond to
neuropeptides such as oxytocin, vasopressin, and corticotropin-releasing hormone (CRH). This proposed
research investigates how sickness disrupts PVN neuropeptidergic circuits to influence maternal caregiving.
Using an acute inflammatory challenge induced by injection of the endotoxin lipopolysaccharide (LPS), I will
examine caregiving behaviors in primiparous and multiparous mice. Preliminary behavioral analyses suggest
that first-time mother mice exhibit reduced caregiving during sickness, increasing the risk of pup mortality. In
contrast, experienced mother mice demonstrate behavioral adaptations that maintain caregiving under similar
conditions. Preliminary in vivo photometry imaging of CRH activity suggests that PVN CRH neurons are highly
active during sickness, as well as changes to PVN oxytocin neuron activity during nursing bouts. This proposal
will test the hypothesis that neuroplasticity in PVN neuropeptide circuits during the postpartum period modulates
caregiving behaviors under inflammatory stress.
The proposed research has two aims: (1) to determine the effects of sickness on PVN neuropeptide circuit
dynamics during caregiving and (2) to investigate how neuroplasticity in the PVN neuropeptidergic system
promotes caregiving in experienced mothers despite illness. These findings will enhance our understanding of
the neurobiological mechanisms underlying maternal caregiving and their resilience to physiological challenges,
advancing knowledge relevant to maternal mental health and offspring survival.

Public health relevance
Project Narrative How mothers allocate caregiving efforts in the face of stress, including sickness, is critical for offspring survival and ecological fitness. The hypothalamic neuropeptides oxytocin, corticotropin-releasing hormone, and vasopressin facilitate caregiving behavior, stress response, and sickness behaviors, but their interplay during inflammatory challenges remains unclear. This proposed research will determine how local hypothalamic neuropeptide circuits in the maternal brain respond to sickness and shape caregiving behavior, advancing knowledge of neuroimmune interactions and maternal health under stress.